Epidemiologic Research and Surveillance in Epilepsy (U01) Component A

Project Summary The long-term objectives of the proposed research are to deepen our understanding of the epidemiology of pediatric epilepsy in a geographic area with a racially and economically diverse population. Children in DC are among the most racially and socioeconomically diverse populations in the country, with approximately 66% Black, 18% white, 11% Hispanic and 5% some other race. A total of 29% of all DC children live below the poverty level, and almost 50% of families are run by a single head of household. DC presents a rich population for study to formulate policies and programs to address the needs of a vulnerable and potentially underserved population. To meet our objectives, the following specific aims will be addressed: (1) determine utilization of healthcare resources, responsiveness of health systems and obstacles to care experienced by children with epilepsy and their families, (2) characterize risk factors, outcomes and comorbidities related to prevalent and new onset pediatric epilepsy, and (3) reassess population-based estimates of epilepsy incidence and prevalence over a 2-year period among children living in DC. In support of Aims 1 and 2, we propose creating a cohort of at least 500 DC children with epilepsy. We will use a self-administered questionnaire to obtain data from the parents of the pediatric cases. This questionnaire will ask questions about personal history of epilepsy, types of care sought and received, comorbidities such as cardiac disease and sleep disorders, family history of epilepsy, and the family and social environment. To supplement these data, medical records will be abstracted for treatment schedules, medication use, epilepsy phenotype, and other health measures. Follow- up data collection is expected to occur every 6 months. In support of Aim 3, we will determine whether previously obtained prevalence and incidence estimates for pediatric epilepsy are accurate and stable over time. This will be performed by using an existing health screening tool, the Behavioral Risk Factor Surveillance Survey, used to obtain data on public health in DC and across the country. We will also examine DC-mandated public school immunization records, maintained by CNMC, that also include an indicator for epilepsy, to compare estimates of epilepsy in school-age children with that found in the telephone survey. Children with epilepsy are a socially and educationally vulnerable group. Characterizing epilepsy in the DC school age population will play a role in better defining the resources needed to provide essential health and educational services to an underserved population. As a community with such rich diversity, DC is an ideal geographical area to implement population-based studies of epilepsy. Results from our study may contribute to recommendations for changes in health policy and guidelines used by primary care providers and neurologists for treatment of children with epilepsy.

Public health relevance
Project Narrative SOS-DC KIDS will deepen our understanding of the epidemiology of pediatric epilepsy and barriers to utilization of care, in a geographic area with a racially and economically diverse population. By defining obstacles to care and identifying needs of the family across a diverse metropolitan population, our study will provide a basis on which to build a more effective approach to pediatric epilepsy treatment in economically disadvantaged groups. Our research may lead to targeted initiatives that will address the deficiencies of care on multiple levels, such as in conjunction with primary care, early intervention, and education which will lead to better outcomes associated with seizure control, socialization, and comorbidities. __SpecificAimsTextDelimiter__ 2. Specific Aims RTI International and the Children's National Medical Center (CNMC) propose to conduct the "Seizures and Outcomes Study in District of Columbia Children" (SOS-DC KIDS) in response to RFA-DP-11-003, Component A: Epidemiologic Research in Epilepsy. The study will deepen our understanding of the epidemiology of pediatric epilepsy in a geographic area with a racially and economically diverse population. Census data and results from previous RTI/CNMC work supported by CDC demonstrate that DC is an ideal location to implement a large population-based cohort study of children with epilepsy. Pediatric epilepsy care is concentrated at two medical institutions: CNMC provides care for over 90% of all pediatric epilepsy cases in DC and Howard University Hospital (HUH) provides care for at least another 5%. Children in DC are among the most racially and socioeconomically diverse populations in the country. Approximately 66% are Black, 18% are White, 11% are Hispanic, and 5% are some other race (US Census Bureau, 2011). Twenty-nine percent of all DC children live in poverty and almost 50% of families are run by a single head of household. Thus, DC presents a rich population for study to formulate policies and programs to address the needs of a vulnerable and potentially underserved population. Three specific analytic aims form the basis of our research strategy: 1. Determine utilization of healthcare resources and obstacles to care experienced by children with epilepsy and their families. Using data collected through interview of a cohort assembled by the study and by searching medical records, we will examine health care resources available to families and how these are utilized and accessed across racial and socioeconomic groups. We will also examine obstacles to care from two perspectives: (1) healthcare provider limitations such as limited hours, lack of bilingual staff, and lack of convenient public transportation; and (2) family-based obstacles such as poverty, cultural bias, caregiver work obligations, lack of social support, lack of knowledge about the disease and family functioning. A detailed discussion of Aim 1 is presented in Section 3.3.6. 2. Characterize outcomes, comorbidities, and risk factors related to prevalent and new onset pediatric epilepsy. Using data collected from the cohort assembled by the study, we will examine differences in diagnoses, treatment and management, comorbidities, outcomes, and social factors by racial/ethnic and socioeconomic indicators. We will also examine parental and patient understanding of risk factors for epilepsy-related outcomes such as poor bone health due to chronic exposure to anti- epileptic drugs, susceptibility to injury, and sudden death (SUDEP). This aim is discussed in detail in Section 3.3.7. 3. Reassess population-based estimates of epilepsy incidence and prevalence over a 2-year period among children living in DC. We previously determined population-based estimates of epilepsy in DC through a CDC-funded study conducted in 2008-2009. Results of this effort are discussed in Section 3.3.1.The brevity of the screening tool used in the study, combined with potential language barriers, may have resulted in some misclassification, particularly involving febrile seizures in childhood or seizures due to acute trauma. It is unlikely such misclassification influenced the active prevalence rate, which was defined by use of medication to control seizures, but the incidence rate may have been overestimated, particularly in young children. We will survey the DC population again, using a population-based sampling method and computer assisted telephone interviewing with a more refined screening questionnaire, to determine the stability of pediatric epilepsy estimates over a 2-year period. We will also examine DC-mandated public school immunization records, maintained by CNMC, that also include an indicator for epilepsy, to compare estimates of epilepsy in school-age children with that found in the telephone survey. More complete details on this Aim are presented in Section 3.3.8. Collection of data needed to realize Aims 1 and 2 will take place through formation of a cohort of pediatric epilepsy patients and their families. Details on development of the cohort are discussed in Section 3.3.5. We will consult with CDC, national experts, and the NIH National Institute of Neurological Disorders and Stroke (NINDS) to further develop and finalize our study plan prior to implementation.